Delivering inhalable nanoparticles containing AI-optimized CFTR mRNA with a novel microfluidic device for treatment of CF

Project summary
Cystic fibrosis (CF) is an autosomal genetic inherited disease caused by over 1,000 known mutations
in the CFTR gene, which encodes an ion transporter. Gene therapy offers a single therapeutic solution
to treat all CF patients, regardless of underlying mutation. Previous gene therapy approaches delivering
CFTR DNA via viral or liposomal delivery have not proven clinically viable. Airway administration of
CFTR mRNA packaged in lipid nanoparticles (LNPs) offers a promising therapeutic approach for CF
patients that is non-invasive, repeatable, and safe. A recent Phase 1/2 clinical trial of CFTR mRNA
delivery using repeated administration of inhaled CFTR mRNA-LNPs demonstrated clinical safety but
did not adequately improve CF endpoints. Advances have been made in LNP material design and
formulation for mRNA delivery to the lungs but clinical feasibility for CF treatment requires additional
therapeutic improvements. One neglected area of innovation is modification and optimization of the
delivered CFTR mRNA cargo. Current therapies use wild-type mRNA or basic codon optimization to
increase translation efficiency of the CFTR mRNA. However, recent advances in AI-based design
provide a significantly better method to optimize both protein translation levels and mRNA half-life. This
optimization would improve the efficacy of CFTR mRNA therapy and potentially reduce dosage and
administration frequency compared to current mRNA cargoes. Another technical limitation is the current
nebulizer technology for aerosolization of LNPs, which physically disrupts nanoparticles, reducing their
effectiveness and necessitating reformulation of LNPs that can diminish their efficacy and provoke
immune responses. New nebulizer technology with reduced LNP disruption would enhance mRNA-
LNP delivery and remove the need for deleterious reformulations. We propose to address the efficacy
gap of inhaled mRNA-LNP therapies by completing the following objectives: 1) employ AI-based mRNA
design with rapid in vitro screening to generate a therapeutic CFTR mRNA optimized for protein
expression, half-life, and ion channel function; 2) utilize mRNA barcoding for rapid in vivo screening of
longevity of these novel CFTR mRNA sequences delivered by nebulizer; and 3) evaluate therapeutic
efficacy and safety of repeated inhaled administration of CFTR mRNA-LNPs using a novel microfluidic
nebulizer device in a rat model of CF. These studies will advance inhalable mRNA-LNP therapies by
applying new nebulizer and computational technologies to address overlooked aspects of airway
mRNA-LNP delivery. This work evaluates new strategies in vitro and in vivo to improve clinical viability
of inhalable LNP delivery of mRNA that provides a noninvasive and repeatable treatment for CF and
other pulmonary diseases.

Public health relevance
Project Narrative Cystic fibrosis is a pulmonary disease caused by mutations in the CFTR gene. One promising therapeutic approach is delivering CFTR mRNA to lung cells in small nanoparticles but the current technology for airway delivery and the CFTR mRNA sequence design has not been clinically effective. We propose using state-of- the-art nebulizer technology for nanoparticle airway delivery and computationally-assisted design to improve mRNA therapies for treating cystic fibrosis.